BASAL LEVELS OF CORTICOTROPIN RELEASING FACTOR AND THYMOPOIETIN IN PANIC DISORDER

The purpose of this study is to provide information on several biochemical and psychological characteristics associated with generalized anxiety disorder. Information will be compared to a control group of individuals.